Live Cell Isoform-specific Akt Analyses

Not Applicable. This proposal is for an NIGMS administrative supplement for equipment
purchase.

Public health relevance
Not Applicable. This proposal is for an NIGMS administrative supplement for equipment purchase.